Elucidating the Relationship Between Cell Proliferation and Invasion

PROJECT SUMMARY/ABSTRACT
Over the last five years, three cyclin-dependent kinase 4/6 inhibitors (CDK4/6i) have been approved for the
treatment of metastatic breast cancer. CDK4/6i prevent cancer cells from dividing by blocking their progression
through the G1/G0 phase of the cell cycle. However, results from in vitro studies reveal that both exogenous and
endogenous CDK4/6i increase the invasiveness of certain forms of cancer. The consequences of G1/G0 cell
cycle arrest on cancer cell behavior in vivo remain unknown. Caenorhabditis elegans anchor cell (AC) invasion
provides an excellent yet simple in vivo model of cell invasive behavior that allows single-cell and subcellular
analysis of cell invasion through basement membrane. Our lab determined that G1/G0-specific arrest is required
for AC invasion to occur and that the nuclear hormone receptor NHR-67/TLX acts as a key regulator of this
process. In the absence of NHR-67, the AC becomes non-invasive but over-proliferates, indicating that
proliferation can increase as invasion is blocked. The long-term goal is to understand both the molecular
mechanisms controlling G1/G0 cell cycle arrest and the in vivo effects of CDK4/6i as individual agents and in
combination with inhibitors of the mammalian target of rapamycin (mTORi). Together, CDK4/6i and mTORi have
been shown to induce senescence in cancer cells in vitro, suggesting that combining these pharmacological
agents might be useful in the clinical setting. The overall objectives of this fellowship application are to (i)
elucidate how G1/G0 is maintained in the C. elegans AC and (ii) determine whether ACs in NHR-67-deficient
animals can be pharmacologically induced to transition from proliferation-to-invasion-to-senescence. Based on
preliminary data and prior research, the central hypothesis is that redundant mechanisms regulate the G1/G0
state of the wild-type AC and that proliferative ACs in NHR-67-deficient animals can be prompted to undergo
senescence. This central hypothesis will be tested by pursuing two specifics aims. Aim 1 will identify the
components regulating G1/G0 arrest in the pro-invasive AC. Aim 2 will evaluate the transition between AC
proliferation, invasion and senescence upon depletion of CDK4/6, mTOR, or both. To address these aims, this
project will use established gene knockdown techniques, high-resolution imaging, and cutting-edge
technologies, including a novel live cell cycle state sensor and two conditional protein depletion systems. The
results of these studies can help guide the development of future treatment strategies for aggressive cancers.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on developing an understanding of the relationship between cell proliferation and cell invasion which is critical for identifying therapeutic strategies that simultaneously inhibit tumor growth and metastasis. Once such strategies have been identified, there is the potential for a significant advance in cancer therapy for patients with advanced malignancies. Thus, the proposed research is relevant to the part of the NCI’s mission that pertains to advancing scientific knowledge and helping all people live lengthier, healthier lives.